Vision Impairment in the National Health and Aging Trends Study

PROJECT SUMMARY/ABSTRACT:

At least 14 million people in the U.S. are blind or living with a vision impairment (VI), and the number affected is projected to double by 2050 due to aging and growth of the U.S. population. The majority of those with VI and blindness are older adults aged ≥65 years. Particularly in later life, VI is thought to be associated with a host of adverse outcomes, including dementia, admission to a long-term care facility, and even mortality. Nonetheless, rigorous and generalizable research on how risk factors impact vision and eye health, and how vision influences late-life outcomes has been limited due to a lack of data that: (i) is longitudinal; (ii) is representative of the U.S. population; (iii) contains objective assessments of visual function; and (iv) samples older adults. In the proposed project, we will address this barrier using newly collected vision data from the NIH-funded National Health and Aging Trends Study (NHATS), an ongoing nationally representative panel study of >7,000 adults aged ≥65 years. In 2021, NHATS began annual measurement of distance and near visual acuity and contrast sensitivity. In Aim 1 of the proposed study, we use NHATS data to provide the first-ever estimates on the incidence of VI and blindness at the national level, as well as national prevalence estimates. In Aim 2, we will evaluate the longitudinal influence of risk factors on vision health. To do so, we will utilize individual-level indicators of risk factors from NHATS and neighborhood level-indicators from the NIH-funded National Neighborhood Data Archive that is linked to NHATS. In Aim 3, we will investigate the longitudinal impact of VI and blindness on the development of dementia, placement in long-term care, and all-cause mortality. In a sub-aim, we will use a longitudinal mediation model to test whether the influence of key risk factors on adverse late-life outcomes is mediated by vision and eye health. To date, it has not been possible to carry out nationally representative studies on the associations of VI with risk factors and key late-life outcomes due to the lack of longitudinal and objectively measured visual function data in a national sample. Thus, the proposed studies will address critical scientific gaps. This proposal is also highly responsive to the National Eye Institute’s new 5-year Strategic Plan, including: (i) to gather current epidemiologic data; (ii) to support research at the nexus of risk factors and the healthcare system; and (iii) to explore research encompassing comorbidities. Epidemiological estimates will be made publicly available, and all study findings will be widely disseminated to maximize the impact of these studies on public health and to optimize vision and overall health and wellbeing for an aging U.S. population.

Public health relevance
Public Health Relevance: The proposed research is relevant to public health because it focuses on providing up-to-date estimates of the number of older adults in the U.S. with vision impairment and blindness, as well as key insights on the associations between risk factors, vision impairment and blindness, and late-life outcomes like dementia, long-term care placement, and mortality. This study will use newly collected vision data from the NIH-funded National Health and Aging Trends Study (NHATS) to conduct longitudinal analyses that are nationally representative of older adults aged ≥65 in the U.S. Thus, the proposed research is relevant to the NIH’s mission to enhance health and reduce illness.